Bridging the Glycome and Proteome with Chemical Biology

PROJECT SUMMARY
Glycoproteins and proteoglycans are important protein glycoconjugates in the cell. They can
control many biological events, such as growth factor signaling, cell adhesion, and differentiation,
to impact cancer biology, development, and immunity. While vital to human health and physiology,
we currently do not have a comprehensive molecular understanding of how these molecules
orchestrate their functions. Many techniques study these molecules in isolation – focusing on only
the protein or glycan component alone. This current approach severely underappreciates the
structural diversity of protein glycoconjugates, and it has left us with a narrowed understanding of
how protein glycoforms can differentially regulate biology. Furthermore, it has impeded pathways
to use glycoform-dependent interactions for drug discovery. Our research program integrates
techniques in chemical biology, molecular biology, and protein engineering, in order to address
these gaps. In this application, we describe our plans to create defined semi-synthetic
glycoproteins and proteoglycans, and to use these materials to study their interactions in live cells.
Identifying the glycoproteins associated with glycan-binding proteins allows the use of targeted
genetic approaches to study their functional contributions. The insights developed from these
studies will create an opportunity to discover small molecules that can selectively modulate
glycan-binding protein and glycoprotein interactions in order to regulate important biological
events.

Public health relevance
PROJECT NARRATIVE Our current understanding of how glycans regulate biological events is limited, marred by the technical challenge of analyzing protein glycoconjugate structure and interactions. Our research seeks to bridge the gap between proteins and glycans by using chemical biology approaches. This program can illuminate the nature and behavior of protein glycoconjugates in living cells in the short term, and it can pave the way towards biomedical interventions to promote health in the long term.